2-Arachidonoylglycerol signaling in anxiety, depression, and stress adaptation

PROJECT SUMMARY Stress is a major risk factor for the development of mood and anxiety disorders and the
causative agent in posttraumatic stress disorder (PTSD). Development of stress-related psychopathology is
variable among individuals and involves complex interactions between susceptibility mechanisms favoring
development of psychopathology and resiliency mechanisms protecting against the development of mental
illness in the face of adversity. Understanding the molecular, cellular, and circuit-level mechanisms by which
stress exposure is translated into affective pathology could have broad implications for understanding the
pathophysiology of stress-related psychiatric disorders and for the development of novel treatment approaches.
We propose to test the overarching hypothesis that the endogenous cannabinoid 2-Arachidonoylglycerol (2-AG)
is a critical regulator of stress adaptation and propose to elucidate the synaptic and cellular mechanisms by
which 2-AG signaling serves to mitigate pathological responses to stress exposure. We will first test the
hypothesis that 2-AG signaling inhibits bi-directional excitatory coupling between the amygdala and ventral
hippocampus, a neural circuit critical for mediating innate danger avoidance and generalization of learned fear
responses. We will test the hypothesis that stress causes a functional collapse of 2-AG signaling within this
circuit leading to synaptic strengthening, the generation of increased avoidance, and fear generalization. We will
also test the hypothesis that stress exposure leads to increases in 2-AG release within distinct amygdala circuits
in a neural activity-dependent manner using a novel virally encoded GPCR-based endocannabinoid biosensor.
These studies will reveal, for the first time, the temporal dynamics and activity-dependent mechanisms mediating
stress-induced endocannabinoid mobilization within amygdala circuits. Lastly, we will use in vivo single-cell
calcium imaging approaches to test the hypothesis that 2-AG is required for the dynamic changes in neuronal
ensemble representations to threat predictive cues that occur during fear learning, expression, generalization,
and extinction. Taken together, these data will provide new mechanistic insight into how 2-AG signaling regulates
stress-related biobehavioral processes relevant to neuropsychiatric disorders including PTSD and could reveal
novel pathophysiological mechanisms contributing to the translation of stress exposure into affective pathology.

Public health relevance
PROJECT NARRATIVE Mood and anxiety disorders are the most prevalent psychiatric illnesses and exert substantial personal and economic burden worldwide. Existing treatments for affective illnesses are only partially effective. Here we aim to elucidate a role for endogenous cannabinoid lipids in the regulation of mood, anxiety and stress responsivity with the ultimate goal of validating endogenous cannabinoid augmentation as a new approach to the treatment of mood and anxiety disorders.